Investigating Close-in-time Mediators and Moderators of SocialMedia Use, Alcohol-related Content Exposure and Young Adult Drinking Behavior

PROJECT SUMMARY/ABSTRACT
Heavy drinking and social media use are common among young adults. However, young adults are often
inaccurate at estimating their social media use, suggesting objective methods such as passive sensing are
needed. Greater self-reported social media use during adolescence has been shown to predict increased alcohol
use during young adulthood. Despite daily variability in heavy drinking and social media use, no research has
examined impacts of close-in-time social media use and ARC exposure on momentary drinking behavior. Due
to its robust prospective association with alcohol use, exposure to alcohol-related content (ARC) on social media
is believed to explain this association. There is also a need to identify close-in-time mediators and moderators
of the associations between social media, ARC exposure, and drinking to inform the development of ecologically
valid interventions that address the effects of social media on alcohol use. Theoretically important mediators
include alcohol-specific feelings of social comparison and social exclusion, whereas putative moderators include
affect, impulsivity, and in-person social contextual factors. To examine the influences of these factors on
momentary drinking, the proposed K99/R00 research will apply a mixed methods approach across four aims.
The specific aims of the K99 phase are to (1) gain an in-depth understanding of what young adults perceive to
be the explanatory and modifying factors for social media use, ARC exposure, and alcohol use, and (2) refine
the measures and methods for examining close-in-time predictors of momentary drinking, including developing
skills for collecting and processing smartphone passive sensing data. Aim 1 will involve conducting qualitative
focus groups with 48 young adults (6-8 per group) and for Aim 2, 20 young adults will complete a pilot ecological
momentary assessment (EMA) study and exit interviews, resulting in a protocol for a full-scale EMA study. The
specific aims of the R00 phase are to (3) examine the relative strength of ARC exposure compared to general
social comparison and social exclusion as mediators of the relationship between social media use (measured
via passive sensing) and alcohol use, and (4) identify mediators and moderators of the association (a priori and
qualitatively informed) between ARC exposure and alcohol use using a EMA-sensing integration study (N= 150;
28 days). To support the research aims, the PI will acquire training from a highly skilled mentorship team in (1)
qualitative methods and analysis (Dr. Barnett), (2) EMA study design (Drs. Barnett and Jackson), (3) passive
sensing data collection (Dr. Bae), (4) advanced multilevel data analysis (Dr. Janssen), and (5) professional and
career skills development (all mentors). Findings will facilitate an understanding of close-in-time mediators and
moderators of ARC exposure and momentary drinking. Completion of the proposed study and training goals will
facilitate a successful transition to independence whereby the PI will establish a program of research using
optimal methods to examine social media implications for young adult alcohol use.

Public health relevance
PROJECT NARRATIVE Young adults experiencing negative consequences from heavy alcohol use is a major public health concern and there is evidence that frequent social media use in young adulthood is related to heavy drinking. The proposed study will first identify possible processes related to social media use and will use technology in participant smartphones and participant reports of alcohol use to determine why seeing ARC may result in alcohol use. Findings from this study may inform the development of interventions to reduce the impact of social media and ARC on heavy drinking.